Pathogenic environmental regulation of miRNA biogenesis and function

DESCRIPTION (provided by applicant): Human exposure to environmental toxicants is a well known cause of disease and low chronic exposure may contribute significantly to longitudinal risk of chronic diseases. Pathogenic mechanisms for many environmental toxicants remain poorly defined which limits development of effective interventions to protect against environmentally-derived chronic diseases. Low dose exposure to trivalent arsenic As(III) in drinking water is a major public health concern that contributes to a number of diseases and pathologies, including cardiovascular and metabolic diseases. While progress has been made in the understanding of the pathogenic signaling events contributing to arsenic-induced disease, many responsible mechanisms have not been elucidated. Control of miRNA expression and action presents a promising new means for understanding downstream effects of arsenic exposure; however, there are few reports of how arsenic regulates expression of miRNA and impacts their function. Thus the proposed studies will use arsenic as an ideal pathogenic environmental toxicant to examine impact on miRNA regulated phenotypic programs. To focus the studies, impact of arsenic on miR-29 family (including miR-29a, 29b-1, 29b-2 and 29c) biogenesis and pathogenic actions will be investigated. This miRNA family was selected based on several studies implicating increased miR-29 members in the etiology cardiovascular and metabolic diseases. Our preliminary data show induction of miR-29 in white and brown adipose tissue isolated from arsenic exposed (100 mg/L in drinking water for 2 wk) mice and in human adipose-derived mesenchymal stem cells (hMSC) as arsenic inhibited adipocyte differentiaton. Reduced stem or progenitor cell differentiation capacity is believed to be a fundamental means for disease progression and we will use the differentiation of hMSCs into adipocytes and cardiomyoctes as a model to examine arsenic effects on pathogenic miRNA regulatory programs. The overarching hypothesis investigated is that arsenic induces transcriptional expression of miRNAs and impacts their function in repressing gene programs that regulate hMSC differentiation thereby impairing regenerative capacity and adaptive repair of cardiac or metabolic tissues. This hypothesis will be studied by the following specific aims: I. Identificatio of the mechanisms regulating arsenic-induced miR-29 family member expression and its functional impact. Mechanisms of arsenic-stimulated miR-29 biogenesis will be studied in hMSC with focus on impaired hMSC, adipocyte and myocyte differentiation. Molecular knockdown of rate limiting steps will identify how arsenic induces the expression and pathogenic role of the miR-29 family members. II. To test the hypothesis that cell context and environmental factors impact the functional activity of relevant miRNA. Focus will be on investigating how arsenic regulates differential activity of miR-29 family members on their mRNA targets. The expression and ability of mRNA binding proteins will be studied in relation to their ability to enhance or reduce miRNA mediated translational inhibition.

Public health relevance
PUBLIC HEALTH RELEVANCE: The environmental basis of chronic diseases is a well recognized public health concern, but is mechanistically poorly understood, including exposure to arsenic in drinking water which is well known to cause significant health effects including cardiovascular and metabolic diseases in populations across the globe. The proposed studies investigate impact of arsenic exposure on miRNA, the newly discovered, small, yet powerful cellular regulators, in pathological responses in adult stem cell pools that impair regenerative or adaptive responsive that prevent disease. This research will identify mechanisms for pathogenic arsenic effects, as well as basic understanding of regulatory mechanisms for miRNA biogenesis and function that may identify novel targets for therapeutic intervention or protection from environmentally-derived disease. __SpecificAimsTextDelimiter__ Specific Aims: Exposure to environmental contaminants significantly impact cardiovascular disease etiology and possibly account for a large portion of idiopathic diseases. However, mechanisms for the pathogenic effects of environmental contaminants are poorly understood, especially in considering low to moderate levels of chronic exposures. Arsenic (As(III)) in drinking water is arguably the most important contaminant affecting cardiovascular disease and is a global public health concern contributing to disease in millions of people worldwide. As(III) directly causes or enhances the potency of longitudinal risks for cardiac and peripheral vascular ischemic diseases, atherosclerosis, hypertension, and diabetes [1-4]. Relative to carcinogenesis, pathogenic cardiovascular effects of As(III) are recognized as being among the most sensitive predictors of its health risks. Indeed, studies in mice [5, 6] and men [2, 3] demonstrated vascular remodeling and vascular disease at or moderately above regulated limits for drinking water As(III) (10-50 mg/L). However, fundamental molecular understanding of the actions and targets of As(III) are unresolved and improved understanding is critical for identifying preventative or therapeutic interventions to reduce As(III)-driven cardiovascular disease. MicroRNA (miRNA) constitutes a new level of physiologic and disease regulation and may play a large role in arsenic-induced disease etiology. While there are only a few reports of arsenic on their actions, miRNAs are increasingly recognized as powerful regulators of cellular processes including differentiation, proliferation, and apoptosis [7, 8]. Understanding the regulation of miRNA expression and their downstream roles is of critical importance to fully understanding disease promotion by environmental contaminants. We propose focused studies of As(III) (an exemplary environmental contaminant) actions on progenitor cell function and differentiation to investigate the hypothesis that As(III) increases repressive miRNA expression in progenitor cells to impair regeneration of metabolic and cardiac tissues thereby contributing to the pathogenesis of cardiovascular disease. Many miRNA are involved in producing pathogenic metabolic and cardiovascular phenotypes [9, 10]. However, for proof of hypothesis, the studies will focus on arsenic-induced expression and action of miR-29 in human mesenchymal cells (hMSC). This focus is supported by our observations of increased miR-29 family member expression in broad miRNA arrays of adipose tissue (but not liver) of mice exposed to arsenic in drinking water (100 mg/L) and in primary hMSC exposed to sub- or low micromolar As(III). In addition, these exposures inhibited hMSC gene and protein expression required for adipose differentiation. Little is known of their role in differentiation; however, miR-29s are implicated in promoting cardiac [9] and vascular injury [11], as well as metabolic disease [10, 12]. From the perspective of basic research, miR-29s, represented by 3 family members with differential action, are ideal models for revealing environmental impact on miRNA processing and post-transcriptional regulation. The objective of this research is identifying mechanisms for miR-29 expression and elucidating its cellular roles and overall function in arsenic-induced disease with the aims: Aim 1: To identify the mechanisms regulating arsenic-induced miR-29 family member expression and its functional impact. Mechanisms for arsenic-stimulated miR-29 transcription, processing will be studied in hMSC with focus on mechanisms for impaired hMSC adipose and myocyte differentiation. Molecular knockdown of rate limiting signaling steps will be used to identify how arsenic induces miR-29 expression and the essential pathogenic role of the miR-29 family members. Aim 2: To test the hypothesis that cell context and environmental factors impact the functional activity of relevant miRNA. Focus will be on investigating how arsenic regulates differential activity of miR-29 family members on their mRNA targets. The expression and ability of mRNA binding proteins will be studied in relation to their ability to enhance or inhibit miRNA mediated translation inhibition. These studies will increase understanding of how environmental hazards, such as arsenic, initiate pathogenic signaling that regulates miRNA expression and action to promote disease. Mechanisms for environmental impairment of progenitor cell function and differentiation will be revealed. This improved mechanistic understanding will be critical for identifying preventative or therapeutic interventions to reduce environmentally- driven cardiovascular and metabolic diseases.